Phase 2 ISC3 Administrative Supplement for Advancing Health Equity through Implementation Science

Project Summary/Abstract (from parent award P50 CA244688)
The theme of our proposed Implementation Science Center is “Pragmatic implementation science approaches
to assess and enhance the value of cancer prevention and control in rural primary care.” We will apply and
advance frameworks, pragmatic methods, and measures related to cost, benefits, and value that are rigorous,
but also generalizable across rural primary care settings that are often struggling with low resources, and a
high need population. These models and methods will be used to guide selection and implementation of
evidence-based programs for cancer prevention and control (CPC). We will initially focus on lung cancer
screening in rural primary care settings, first in Colorado and then nationally through collaboration with a well-
established primary care network (i.e., National Research Network).
Our overarching framework will be our enhanced RE-AIM/PRISM model, which is an extension of the broadly
used Reach, Effectiveness, Adoption, Implementation, and Maintenance framework with the addition of
contextual factors (e.g., Intervention characteristics, implementation and sustainability infrastructure). It will
serve as the basis to develop and test innovative assessments of costs, benefits, and value from the
perspective of different stakeholders to understand and guide implementation. We will meaningfully engage
with and include the perspectives of patients, providers, and staff stakeholders in all our studies. Our pilot
Implementation Study will adapt, implement, and evaluate strategies using stakeholder-engaged approaches
to value to guide the implementation of shared decision-making and smoking cessation related to lung cancer
screening.
Our Methods Unit will refine and evaluate our pragmatic cost assessment methods to determine
implementation/replication costs from the perspective(s) of patients, providers, and delivery staff and then
develop and pilot test brief survey measures of preferences regarding the relative benefit of different RE-AIM
outcomes. We will then assess relationships among RE-AIM outcomes preferences and selection of different
CPC programs. Finally, our Outreach and Network Unit will engage in a) outreach activities targeted at junior
and mid-career investigators and practitioners including online professional development (e.g., graduate
certificate program, micro-certification) and tailored mentoring and technical assistance approaches; b)
dissemination activities to support the packaging and communication of research findings; and c)
collaboration activities to facilitate partnerships on CPC and implementation science using multiple channels
and including development of shared pragmatic D&I measures and data.

Public health relevance
Project Narrative (from parent award P50 CA244688) We propose an Implementation Science Center for Cancer Control with a focus of developing, validating, and sharing innovative, pragmatic models and methods related to the costs, benefits, and value of translating evidence-based cancer control programs and guidelines into rural primary care practice settings. Our theme is ‘Pragmatic implementation science approaches to assess and enhance the value of cancer prevention and control in rural primary care.’ These approaches will inform strategies to implement lung cancer screening and other cancer prevention and control interventions and advance implementation science by providing measures, reporting guides, resources, training, and certification of competence.